Shared Resource-Advanced Biophotonics Core

Advanced Biophotonics Core Shared Resource - Project Summary/Abstract
The Advanced Biophotonics Core (ABC) provides imaging and analysis instrumentation coupled with technical
and collaborative support staff for advanced light and electron microscopy of biological systems. Cancer
Center members use the facility for high-throughput imaging assays, high-resolution imaging of live cell and
tissue dynamics, super-resolution microscopy, large 3D volume imaging of tissues, electron microscopy
analysis of subcellular morphology and protein distribution, and automated computational image processing,
visualization, and analysis. The ABC Core is also actively pursuing and developing new cutting-edge imaging
and analysis methodologies to better serve the needs of Cancer Center researchers, such as cryo-correlative
light and electron microscopy, light-sheet imaging of cleared and expanded tissues, and machine-learning
based processing, segmentation, and analysis of light and electron microscope images. The ABC Core is
committed to providing Cancer Center members: 1) access to light and electron microscopes, specialized
sample preparation reagents and technologies, and computational hardware and software for analysis and
visualization, 2) free one-on-one training on all microscopes, as well as image processing and analysis
software, 3) consulting and collaborative support for experimental design and implementation of imaging and
analysis experiments, 4) sample preparation for electron microscopy, tissue clearing, and expansion
microscopy, 5) workshops and demos with advanced microscope and software technologies, 6) weekly open-
door imaging boot camp on advanced imaging and image processing techniques, and 7) a monthly
Biophotonics scientific seminar series followed by town-hall style discussions with ABC Core staff and users.